Neuronal Control of Appetite, Metabolism and Weight

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Neuronal Control of Appetite, Metabolism and Weight, organized by Drs. Tony K.T. Lam and Matthias H. Tschop. The meeting will be held in Banff, Alberta, Canada from March 17 - 22, 2013. The general topic of this meeting is relevant to the NIDDK mission with respect to metabolic diseases and disorders research. Obesity and Type 2 diabetes are associated with a disruption in energy, glucose and lipid homeostasis. Exciting new developments indicate a key role for the central nervous system in the homeostatic control of systemic metabolic processes and ultimately body weight. A goal of the Keystone Symposia meeting on Neuronal Control of Appetite, Metabolism and Weight is to bring together basic and clinical scientists from academia and the pharmaceutical industry studying neuronal control of appetite, metabolism and body weight or related complementary fields (such as addiction/reward, cellular stress, and inflammation) to share novel and relevant insights with relevance for human obesity, diabetes and metabolic disease. The meeting seeks to integrate existing knowledge with novel discoveries on central nervous system mechanisms activated by hormones or nutrients that regulate systemic metabolism. Meeting participants will discuss the latest research in this field along with future directions and perspectives that are relevant for both basic science and clinical research.

Public health relevance
Obesity is an increasingly common disorder and has become a leading cause of morbidity and mortality worldwide. Therefore, the identification of critical integrative neuronal systems that control both energy balance and glucose metabolism has important implications for the future of obesity therapy. The 2013 Keystone Symposia meeting on Neuronal Control of Appetite, Metabolism and Weight seeks to integrate existing knowledge with novel discoveries on central nervous system mechanisms activated by hormones or nutrients that regulate systemic metabolism.